Scalable Non-viral Gene Delivery for Neuromuscular Diseases

The most common adult-onset muscular dystrophy, myotonic dystrophy type 1 (DM1), is caused by the
expansion of an unstable CTG-repeat (50-4000 copies) in the myotonic dystrophy protein kinase (DMPK)
gene. Expression of non-coding nucleotide repeats of DMPK mRNA leads to toxic DMPK mRNA in muscle
cells triggering wide-ranging clinical features of DM, like muscle hyperexcitability (myotonia), progressive
skeletal muscle weakness and degeneration (myopathy), cardiac conduction defects, and cataracts. There is
no effective treatment for this devastating disorder. We propose to test natural cell-derived nanovesicles to
modulate toxic DMPK mRNA selectively and efficiently to improve safety and decrease costs compared to
expensive risk-prone viral-mediated gene therapy.
In Phase 1 of this SBIR project, we aim to validate interfering RNA-loaded nanovesicles in vitro by screening
up to 15 different siRNAs targeting unique regions of the DMPK gene, identify the optimal constructs that
reduce toxic DMPK mRNA in human induced pluripotent stem cells (iPSCs) derived from myotonic dystrophy
patients, and ultimately guide the local and systemic studies in an animal model of disease proposed in Phase
2.
In Phase 2, we propose to generate IND-enabling data for a commercial product. Once a lead nanovesicle
construct is identified in Phase 1, we will compare the efficacy of nanovesicle delivery in a DM1 mouse model
following intramuscular (IM) injections in comparison to AAV delivery of DMPK RNAi. The resulting data will
inform the nomination of a development candidate (DC) for systemic dose-finding and safety studies in a GLP
setting.
Altogether, the experiments proposed here are aimed to advance preclinical technology for nanovesicle DMPK
RNAi as a viable therapy for myotonic dystrophy patients. If successful, this project can serve as a benchmark
for neuromuscular diseases with similar gain-of-function mutations.

Public health relevance
Gene delivery using adeno-associated viral (AAV) vectors for genetic diseases are promising, but fraught with high cost, toxicity, and immunogenicity. Kinea Bio and its partners propose to validate non-viral gene delivery using human cell-derived nanovesicles in a myotonic dystrophy type 1 (DM1) model.